Prenatal Genetic Diagnosis by Genomic Sequencing: A Prospective Evaluation

Project summary/Abstract
Our present R01 funding (R01HD055651) is actively investigating the clinical utility and value of
prenatal sequencing of fetal structural anomalies in clinical care. Our work has demonstrated
the complexity and uniqueness of the fetal genome and the associated phenotypes. To address
this complexity, we developed an international consortium of other sites involved in fetal
sequencing, which meets bi-weekly to discuss their experience. There are numerous limits to
this informal model and it has illustrated the need for a single, collaborative, domain specific
genomic and phenotypic data repository.
Combining our efforts with genomics leaders at The Broad Institute and The Jackson
Laboratories, we aim to develop a fetal genomic and phenotypic data repository consistent with
NIH guidelines for data management and sharing and inclusive of the FAIR goals of findability,
accessibility, interoperability and reusability. Building this data repository using cloud
infrastructure at The Newborn Screening Translational Research Network (NBSTRN) will
incorporate innovative tools and expertise from a number of partners similarly working in
genomics and in the perinatal continuum to improve data sharing and collaboration. Additional
expertise will be provided to support his project from The Global Alliance for Genomics and
Health (GA4GH) along with the parent grant study sites, academic, and industry partners
providing pilot data. We anticipate that, when completed, this repository will serve as a major
resource for investigators and clinicians working in the fields of genomics, developmental
biology, and perinatal medicine. This assembled team will seek to address this critical unmet
need to aggregate and harmonize a central repository of fetal genomics data.

Public health relevance
Project Narrative Birth defects occur in approximately 3% of all pregnancies. Recent research has demonstrated that a significant portion of these have an underlying genetic cause. Since many of these disorders are individually rare, collaboration among centers is required to study this. This project will build a repository of such findings that can be shared among investigators and physicians with the hope of improving diagnosis and developing treatments.